Aristotelia Alkaloids as Probes for the Nicotinic Acetylcholine Receptors

ABSTRACT
The nicotinic acetylcholine receptors (nAChRs) have been implicated in a variety of central nervous system
(CNS) disorders. However, the significant similarity between subtypes has limited the discovery of subtype-
selective nAChR antagonists. As a result, the pharmacological utility of the nAChRs depends on the development
of improved ligands. Recently, several alkaloids isolated from Aristotelia chilensis were identified as nAChR
antagonists that preferentially antagonize the α3β4 subtype over the α4β2 and α7 subtypes. While other α3β4
antagonists exist, they also have poor pharmacokinetic properties and multiple off-target liabilities, making the
subtype-selectivity the Aristotelia alkaloids possess particularly unique. In addition, preliminary competitive
studies indicate that these alkaloids act through an allosteric mechanism of action, in contrast to other
antagonists that are largely orthosteric ligands or channel blockers. Previous studies of the Aristotelia genus
have identified >30 unique alkaloids, but few studies have been conducted on their biological activity. My central
hypothesis is that these understudied Aristotelia alkaloids are also subtype-selective nAChR antagonists that
operate through an allosteric mechanism of action. To investigate this, in Aim 1, I will extract alkaloids from the
leaves of A. chilensis through a novel countercurrent chromatography approach, isolating known natural
products while also potentially discovering novel alkaloids. In a complementary approach, Aim 2 seeks to access
known Aristotelia alkaloids via a series of biomimetic transformations. Armed with a library of alkaloids, Aim 3 will
evaluate their activity at multiple nAChRs through a functional assay. Competitive inhibition studies will be done
to investigate the potential allosteric mechanism of action, while mutagenetic analysis will identify which residues
on the receptors are crucial for activity and reveal differences between subtypes. While making synthetic
advancements, this research is both innovative and significant as it will be the most extensive biological
evaluation of the Aristotelia alkaloids to date, providing tools to probe the nAChRs as a whole, as the alkaloids
establish an entire class of subtype-selective nAChR ligands.

Public health relevance
NARRATIVE The nicotinic acetylcholine receptors (nAChRs) are crucial membrane-bound receptors found throughout the central nervous system that have been implicated in a variety of disease states. High levels of similarity between nAChR subtypes, however, have limited their pharmacological utility, as few ligands that are both selective and potent have been identified. This proposed project investigates a series of alkaloids from Aristotelia chilensis, accessed through isolation and biomimetic synthesis, for their activity as subtype-selective nAChR antagonists, which will lay the foundation to develop new tools to improve the field’s understanding of the nAChRs.